Role of Extracellular Matrix Assembly in a Tissue Differentiation Model Probed with a Novel Fibronectin Mutant

7. Project Summary
The proposed work seeks to use a novel mutation in the extracellular matrix (ECM) protein fibronectin
(FN) to study the role of proper ECM assembly in tissue development. The ability of cells to assemble and
manipulate the ECM is crucial in tissue development, maintenance, and remodeling. Proper ECM production
and function is at the heart of a staggering range of physiologic processes, while dysregulation of the ECM
causes and contributes to many diseases. The study of mutations in various ECM components has been
instrumental in understanding these proteins' processing, function, and significance in physiology and
pathology. The FN matrix specifically is critical in early ECM formation, serving as an essential framework for
the development of the ECM and in guiding the incorporation and assembly of other ECM proteins and growth
factors into the matrix. Despite its importance, we lack information about how the FN matrix develops and how
matrix assembly directs cell and ECM development. This in turn limits our ability to understand normal tissue
physiology and to develop treatments for diseases caused by defects in ECM assembly and organization. Our
limited understanding is in part due to a lack of naturally occurring FN mutations, as complete knockout of FN
expression is lethal to the developing embryo. The recent discovery of a FN point mutation in an individual with
disordered skeletal development represents a powerful opportunity to study how this point mutation in FN's
assembly domain reduces the amount of ECM (Aim 1) and how reductions in matrix affect cellular behavior
(Aim 2). Because FN matrix assembly is the first step in construction of a tissue-appropriate ECM, we
hypothesize that perturbations of FN matrix assembly early in a developing tissue will disrupt the organization
of the ECM and the cell rearrangements and changes in gene expression that are required for cell
differentiation. To test this hypothesis, in aim 1, we will perform an analysis of why fibroblasts with a FN
assembly domain mutation form reduced FN and type I collagen matrices. We will assess the ability of mutant
FN to bind to other FN molecules, track the secretion and fates of different ECM proteins, and look at the
impact of a FN mutation on the assembly of other ECM components. In aim 2, we will study the ability of these
mutant stem cells to initiate the early stages of tissue development using a model for chondrogenic
differentiation, and investigate the impact of deficiency in different ECM components on this development
process. This work will provide novel understanding of the effects of a de novo mutation in human FN on
matrix assembly, how ECM assembly directs tissue development and cell differentiation, and how
perturbations in ECM assembly can lead to developmental defects and disease. Our characterization of this
mutation will also lay the groundwork for thoroughly studying any other FN mutations implicated in human
disease.

Public health relevance
8. Project Narrative The extracellular matrix is a network of proteins that organizes cells into tissues. Though the extracellular matrix is involved in almost every human disease – from diabetes and cancer to liver failure and lung disease – we still do not fully understand how the matrix controls cell functions. This work will use a recently discovered mutation to study the matrix assembly process so that we may better understand how mistakes in assembly lead to mistakes in development and disease.